Hypertension Treatment in Nigeria Program

PROJECT ABSTRACT
This renewal application (R01HL144708) seeks to evaluate and expand upon the successful research
conducted during the initial funding period to address the public health impact of hypertension and diabetes in
Nigeria. Following a formative research period and based on the WHO ExpandNet framework, we propose to
evaluate the effectiveness and implementation of scaling up of the HEARTS multilevel bundle in improving
hypertension control in 50 new primary healthcare centers across five states using a type II hybrid study
design. We will also evaluate the effect of diabetes service integration through the HEARTS-D bundle on
diabetes control and process of implementation into 10 previously enrolled primary healthcare centers in the
Federal Capital Territory. The study will explore the sustainment of hypertension services in primary healthcare
centers that participated in the initial funding period in the Federal Capital Territory using the DHIS-2 health
management information system platform. During the initial funding period, we achieved significant milestones,
including: 1) exceeding our recruitment targets, 2) implementing a supportive supervision program and drug
revolving fund alongside HEARTS, 3) achieving and sustaining hypertension control rates of >50% for nearly
two years, and 4) demonstrating normalization into routine care and high measures of sustainability. The
program has become one of the largest hypertension control initiatives in Africa, with impressive results and
rigorous assessment methods leading to >10 publications. Through the proposed renewal, we will expand our
efforts to Nigeria’s five other geopolitical zones, thus conducting the largest assessment of hypertension care
scale-up in Africa. The integration of diabetes services into primary care settings is also a critical focus, given
the growing burden of diabetes in Nigeria. We have established, strong collaborations with national, state, and
local stakeholders, including government health agencies, policymakers, and healthcare providers. We use
contemporary dissemination and implementation science methods, including the WHO ExpandNet framework
for scale-up, the Implementation Research Logic Model to assess implementation outcomes, including cost,
Normalization Measure Development (NoMAD) to assess normalization into routine care, and the Program
Sustainability Assessment Tool (PSAT) to evaluate sustainability beyond the funding period. The renewal
period offers an opportunity to advance the field of cardiovascular dissemination and implementation science,
while contributing to the knowledge of effective management of non-communicable diseases in primary care
settings in a middle-income country setting. This high-impact research has a high likelihood of driving
sustained change to improve health outcomes in Nigeria and beyond and is aligned with NHLBI strategic
priorities. The University of Abuja will also serve as the primary institution for the renewal, ensuring the
program's sustainability beyond the funding period.

Public health relevance
PROJECT NARRATIVE Nigeria faces a large and growing burden of cardiovascular disease, yet screening, diagnosis, and management of major risk factors like hypertension and diabetes have not been widely integrated into primary care. This renewal application (R01HL144708) builds off our team’s success at achieving >50% hypertension control for nearly 2 years among >21,000 patients (>142,000 visits) recruited from 60 primary healthcare centers in the Federal Capital Territory by implementing the WHO HEARTS multilevel bundle. We propose to: 1) conduct formative research to prepare for scale-up based on the WHO ExpandNet framework, 2) evaluate effectiveness and implementation HEARTS scale-up to improve hypertension control in 50 new primary healthcare centers in 5 new states across Nigeria using the Implementation Research Logic Model, and 3) evaluate the effect of diabetes service integration through the HEARTS-D bundle on diabetes control and process of implementation into 10 previously enrolled primary healthcare centers in the Federal Capital Territory.